Admin Core

Summary
Administrative Core
This core will maintain and enhance an optimally synergistic environment for the proposed research. The
efforts of the director (Hogquist), associate director (Jenkins), and staff (Bethke), will be to enhance the
interactions of the group, carry out proper management of program resources, and arrange for Program
evaluations. All of these we expect will maximize the productivity of the Program.